The design principles of the eukaryotic cell: uncovering the coordination of systems-level organelle dynamics, metabolism and growth

Project Summary
Perhaps the defining feature of the eukaryotic cell is its organization into biochemically distinct compartments
known as organelles. While the biochemical functions of individual organelles are often well known,
how cells regulate the copy numbers, sizes, and subcellular positions of its diverse organelles in a coordinated
fashion and how organelles interact to produce integrated physiological outputs remain one of the grand
challenges in cell biology. The goal of my research program is to discover the quantitative principles
governing how cells regulate systems-level organelle dynamics to coordinate metabolism, growth, and
proliferation. To achieve this goal, my research strategy will proceed along two directions. In the first
direction, I will quantitatively determine how cells coordinate systems-level organelle dynamics with cellular
growth demands. Specifically, I will quantify and build a mathematical model of the relationship between
cellular organelle composition and cell growth. The model will be calibrated from data obtained by
simultaneously visualizing all major metabolic organelles using our machine learning-based hyperspectral
imaging platform, exerting chemical biological control over cell growth and proliferation rates, and genetically
perturbing key organelle biogenesis, organization, and interaction factors. In the second direction, I will
determine how cells coordinate systems-level organelle dynamics and gene expression to control metabolism
during growth and proliferation. I will categorize single cells according to their organelle content and
systematically measure the temporal correlations in their expression of genes whose products execute
organelle-specific functions. I will concomitantly measure the metabolomic profile of these cells sorted by
organelle content. I will then combine these measurements to develop a mathematical model that quantitatively
captures the connection between gene expression and metabolism as mediated by the cell's organelle
makeup. I will subsequently test predictions of this model by systematically tuning organelle interaction
strengths by modulating the expression of organelle biogenesis factors and organelle contact sites. Successful
investigations along these two directions will yield mechanistic insight into how to untangle the complex
interdependencies between organelle dynamics, metabolism, and cell growth and proliferation. A systems-
level understanding of how organelle composition and interactions coordinate metabolism to control cellular
growth and development will lay a rigorous foundation into future investigations into how the cell actively
shapes its organelle composition to match biochemical supply with physiological demand through, how this
plasticity is leveraged in health by multicellular organisms to provide the metabolic flexibility needed to develop
its myriad cell types, but also in disease by allowing for multiple routes to metabolic pathologies in cancer,
diabetes, and aging.

Public health relevance
Project Narrative Public Health Relevance: In eukaryotes from single-celled fungi to mammals, metabolism takes place in the context of cells organized into spatial compartments known as organelles. In this proposal, we seek to illuminate the fundamental quantitative principles by which the cell coordinates the dynamic properties of its organelles, their regulation by gene expression, and the role coordinated organelle dynamics plays in cellular growth and metabolism. Knowledge of these principles can help uncover mechanisms underlying how cells develop normally into cell types and how in the context of disease, such as cancer and diabetes, they remodel their organelle composition to handle altered metabolic profiles and thus point toward potentially new targets for therapy.